Defining Structural and Molecular Mechanisms of The Human Multifunctional Mitochondrial Protease, LONP1

PROJECT SUMMARY
Integrated quality control (QC) systems are required to sense and manage mitochondrial stress, and their
dysregulation is associated with neurodegenerative disease, aging, and cancer. The human ATP-dependent
AAA+ protease, LONP1, has emerged as a master regulator of mitochondrial functions and is an integral
component of mitochondrial QC systems. Deletion of LONP1 in mice is embryonically lethal and altered LONP1
activity is associated with mitochondrial diseases, aging, and cancer. LONP1 classically functions by degrading
oxidatively damaged and unfolded matrix proteins, but also regulates diverse aspects of mitochondrial biology
by specifically targeting and degrading folded proteolytic targets such as transcription factor A (TFAM) and
cytochrome C oxidase subunit IV (COXIV). Additionally, LONP1 is a single stranded DNA binding protein that
localizes to the non-coding control region of mitochondrial DNA, which is important for transcription and genome
replication. LONP1 assembles as a 600 kDa hexamer composed of an N-terminal substrate binding domain
(NTD), a AAA+ ATPase domain, and a C-terminal protease domain and can function as a protease, a chaperone,
or a DNA binding protein. Despite these diverse critical functions, we lack detailed molecular mechanisms
describing these activities and their regulation, limiting the fields capacity to determine their specific roles in
mitochondrial homeostasis or disease pathogenesis. Recent cryo-electron microscopy (cryo-EM) studies have
provided crucial insights into LONP1's conserved, AAA+-mediated hand-over-hand substrate translocation
mechanism required to processively engage, unfold, and degrade proteolytic substrates. Strikingly, in these
structures, the C-terminal protease domains remain in an inactive conformation even with substrate bound to
LONP1's AAA+ domain. These findings contrast recent work on the evolutionarily related bacterial Lon protease
and suggest that LONP1 has evolved additional levels of regulation to control or tune proteolytic activity to meet
cellular needs. Moreover, these results raise important questions regarding proteolytic regulation and its
relationship to other reported cellular functions, including DNA binding. Therefore, the long-term goal of this
proposal will be to establish mechanistic models for LONP1's manifold functions and their allosteric regulation
in order to define their role in mitochondrial maintenance and disease. I hypothesize that LONP1 adopts distinct
structural conformations allosterically regulated by nucleotide state, substrate binding, and/or posttranslational
modifications to shift between operational modes to modulate proteolytic and mtDNA binding activities. I will
integrate structural studies using cryo-EM with biochemical assays to identify allosteric mechanisms involved in
regulating LONP1's proteolytic activity (Aim 1) and elucidate the molecular mechanism and conformational state
required for LONP1's mtDNA binding activity (Aim 2).

Public health relevance
PROJECT NARRATIVE Integrated quality control (QC) systems are required to sense and manage mitochondrial stress, and their dysregulation is associated with a number of diseases including neurodegenerative disease, aging, and cancer. The human ATP-dependent AAA+ protease, LONP1, has emerged as a master regulator of diverse mitochondrial functions, is an integral component of mitochondrial QC systems, and alterations in its activity are implicated in mitochondrial diseases, aging, and cancer. This proposal will provide structural and mechanistic models describing the allosteric regulation and control of LONP1's proteolytic activity and determine the molecular mechanism and conformational state required for LONP1's single-stranded mtDNA binding activity.